Analysis Core

REVISED ABSTRACT: ANALYSIS CORE
The Analysis Core (AnC) plays a critical role in the activities and productivity of the Michigan Center for
Contextual Factors in Alzheimer’s Disease (MCCFAD). Supporting MCCFAD’s three priority areas of:
epidemiology, health economics, and tailored care as well as the long-term goal to advance ADRD relevant
social and behavioral science research in minority communities while increasing the research workforce
dedicated to healthy aging, the AnC ensures the highest possible impact of our Center’s research and
discoveries. Building on our successes in intensively mentoring both primary and secondary data projects, we
will formally expand our educational programs beyond valid and reliable measurement to include appropriately
applied analysis and interpretation, promote sustainable mentoring that is both flexible (to the needs of each
AD-RCMAR Scientist [RS] and project) and proactive (in ensuring essential skills are developed), and facilitate
the use of MCCFAD’s new Research Volunteer Directory (RVD). Corresponding to these areas of importance,
the AnC proposes three Specific Aims: Aim 1: Provide an enriched environment to ensure scientifically reliable
and valid measurement, analysis and interpretation; Aim 2: Provide flexible and proactive mentoring in stateof-
the-art methods, analysis and software; Aim 3: Disseminate methodological developments in tailored
recruitment, measurement and analysis approaches; increase access to new data resources produced. The
AnC ensures thoughtful and thorough methodological approaches and provides consultations at every stage
of Center-wide analytic activities and RS projects. They will continue to work closely with the Research and
Education Core (REC) to assist, mentor and support RS to become independent investigators in ADRD related
research by providing an enriched learning environment to increase their analytic and research skills. They will
also continue to work closely with the Community Liaison and Recruitment Core (CLRC) to ensure state-ofthe-
art measurement and support data visualizations and data access involving the RVD. With our multidisciplinary
and highly experienced AnC leadership team and Center faculty, the AnC is exceptionally wellequipped
to ensure that the MCCFAD makes seminal contributions to innovative ADRD disparities research
across the region and nationally.